DETERMINE IN VITRO ACTIVITY FOR MEDICATIONS DEVELOPMENT

In brief, the objectives of this contract are to determine the in vitro affinity and intrinsic activity of novel test compounds at multiple opioid receptors. The data generated will be utilized by the NIDA Medications Development Division (MDD) Opiate Treatment Discovery Program in the selection of compounds for in vivo preclinical evaluations. The data will also become part of the NIDA MDD structure-activity database, which serves to aid in the design of novel, selective, opioid receptor ligands. In addition to obtaining in vitro opioid receptor binding and bioassay data on novel test compounds, the contractor will devote a substantial number of person hours to the development of relevant new receptor binding and functional activity assays.